Clinical Core

Point of Care Technologies for Nutrition, Infection and Cancer for Global Health (PORTENT)
4.0 Clinical Translation and Validation Core
Abstract
The Clinical Translation and Validation Core is a unique differentiator for PORTENT – one that has been
established through many years of capacity building by the leadership. Consisting of a one-of-a-kind
worldwide network of partner clinical sites in New York, Uganda, Ecuador and India, this network will
provide access to a much more diverse range of clinical populations, clinical and community expertise,
and biobanks than are currently accessible to PoC developers. The core has been structured to be
responsive to the needs of the center, allowing us to allocate funds and resources to sites where clinical support
is best matched to the validation and training needs of the projects. Each site will have a baseline budget to
enable local capacity building with the goal of further establishing them as recognized worldwide centers
of excellence in PoC diagnostic validation before the end of the proposed effort. The core will focus on four
main goals: (1) to enable human and clinical validation of PORTENT center and POCTRN network developed
Point-of-Care (PoC) technologies by providing access to a wide array of sample biobanks and unique patient
populations, (2) to support the design (including statistical support) of validation studies conducted by the project
teams, (3) to work with the Tech Core to identify new and existing PoC projects which can be transitioned to
human validation and the Dissemination Core to develop the annual needs assessment consensus, and (4) to
provide access sites for developer clinical rotations. The establishment of this clinical network will be
transformative to the development and translation of PoC devices for global health because it will
significantly lower the barriers for developers to target their technologies to this broader set of
populations. As noted in our needs assessment, patients in LMICs are some of the most vulnerable in the world
and are located where access to PoC technology could have the highest impact. Success with PORTENT could
significantly improve local health outcomes in these areas.